GENETIC FACTORS GOVERNING MALARIAL IMMUNOLOGIC RESPONSE

This study investigates the nature of the immune response to malarial antigen in adult individuals of Papua New Guinea, focusing on aspects of immune response as they relate to a particular antigen of the malarial parasite at the liver stage(LSA1). Candidates for epitopes, as potential targets for immune response, are identified by the presence of alternating hydrophobic and hydrophilic regions, and artificial epitopes for immune response studies are created. These studies address two specific aspects of immune response to this malarial antigen: First, whether or not there is evidence for distinct populations of responders and non-responders to each of these candidate epitopes, and second, whether the level of response is related to the presence of any of the HLA antigen specificities. The findings may shed some light on potential HLA-restriction operating in the immune response to malaria. Finally, the findings may have implications for our understanding of the host-parasite interaction, and ultimately for vaccine research.